Molecular Basis of Insect Olfaction

Insects such as mosquitoes use volatile odors to localize humans for blood-meals, incidentally spreading
potentially lethal diseases to hundreds of millions of people worldwide each year. To better manipulate insect
behavior with repellents and traps, we must understand how the insect olfactory system works at the level of
genes, molecular signaling networks, olfactory neurons, and anatomical sensory units known as sensilla. This
proposal focuses on the molecular and cellular mechanisms that allow olfactory neurons to robustly signal
environmental odors, with a particular interest in evolutionarily conserved mechanisms. Given our focus on
critical, yet previously unstudied genes, we employ Drosophila as a model system due to the ease of generating
new genetic mutants and transgenic tools. We also utilize existing tools to perform targeted manipulations of
specific populations of antennal cells including olfactory neurons and their support cells. A further advantage of
Drosophila is that we can repeatedly target the same olfactory neuron populations for functional assays based
on foundational knowledge of their antennal localizations and odor response profiles. Using genomic, molecular,
histological, electrophysiological, and behavioral approaches, our recent research has led to the discovery of
several conserved signaling molecules that play critical roles in insect olfaction. This proposal builds upon our
prior research to more deeply understand the mechanisms by which these molecules and others affect olfactory
neuron responses to odors. Particular attention will be paid to the poorly understood intercellular connections
within sensilla, such as interactions between olfactory neurons and the three types of non-neuronal support cells.
Together this research will make powerful molecular inroads into the signaling networks and intercellular
interactions supporting insect olfactory behavior, some of which may be shared with other sensory systems.

Public health relevance
Project Narrative Most insects rely on their sense of smell to select food sources, and this contributes to the spread of diseases such as malaria. This research will investigate how the function of their odor sensing system is supported by conserved molecules and interactions between antennal cells. Insight from this work may also reveal foundational principles contributing to sensory systems in other organisms.